HALOPERIDOL, OLANZAPINE &RISPERIDONE IN CHILDREN W/ PSYCHOTIC DISORD

The broad aim of this study is to provide badly needed information about the benefits and risks of three widely used antipsychotic agents with different mechanisms of action and side effect profiles, haloperidol (HAL), olanzapine (OLA) and resperidone (RIS) in children and adolescents with severe psychotic disorders. This project will rigorously compare the acute and longer term effects of HAL, OlA and RIS, in children. Specifically, data from at least 60 adolescents who are acutely psychotic and will have been randomly assigned in a double blind fashion to treatment with either HAL, OLA or RIS (supplied by Janssen Pharmaceuticals) for six weeks will be evaluated. Individuals who show a positive response will continue treatment under blind conditions for an additional fourteen weeks resulting in a total follow-up period of five months.